National Cancer Institute (NCI) Early Career Cancer Clinical Investigator Award (ECIA) P30 Administrative Supplement

PROJECT SUMMARY/ABSTRACT
As an academic radiation oncologist with subspecialty expertise in head and neck cancer and hematologic
malignancies and additional research interests in cancer control, symptom management, and quality of life, I am
committed to advancing the mission of the National Cancer Institute (NCI) through leadership and excellence in
clinical cancer research efforts within multiple NCI-sponsored institutions. I am a member of the Atrium Health
Wake Forest Baptist Comprehensive Cancer Center (AHWFBCCC) and an Assistant Professor in the
Department of Radiation Oncology at Wake Forest University School of Medicine. I am actively involved in clinical
research through AHWFBCCC investigator-initiated trials (IITs), national cooperative group trials, and multi-
institutional industry studies; however, I wish to advance my career to the next level of leadership in institutional
and national NCI-supported clinical research. With the support of this NCI Early Career Cancer Clinical
Investigator Award (ECIA), I aim to rapidly complete current institutional clinical trial work, expand current pilot
studies into larger NCI-supported clinical trials, complete dedicated training experiences (including coursework
and workshops) and grow my network, responsibilities, and leadership roles within AHWFBCCC and NCI-
supported clinical trial networks such as the Wake Forest NCI Community Oncology Research Program
(NCORP) Research Base and NRG Oncology. To achieve these goals, I will collaborate with mentors within my
institution and within other NCI-funded clinical research organizations to complete two ongoing IITs and develop
an AHWFBCCC pilot study. I plan to report the results and use study findings to inform the design of prospective
studies that can enroll patients within AHWFBCCC-Levine Cancer enterprise and beyond; the WF NCORP
Research Base or NRG Oncology, for example. I will meet with mentors and institutional study staff routinely to
ensure successful and timely completion of my ongoing IITs and the planned study. I will also meet regularly with
mentors and collaborators within the Wake Forest NCORP Research Base and NRG Oncology Head and Neck
Committee and affiliated patient-reported outcome and recurrent/metastatic working groups. I will complete
seminars, workshops, and educational activities to expand my expertise in clinical trial conduct, biostatistical
principles, and patient-reported outcomes research. I will obtain a Certificate in Leadership from the Wake Forest
University School of Professional Studies. These activities would not be feasible without the support and
protected time provided by the ECIA. After successful completion of the proposed activities, I will have
significantly advanced my goal of becoming an independent clinical cancer researcher focused on maximizing
cancer outcomes, minimizing radiotherapy toxicity, and improving the health and quality of life of patients in
survivorship after successful treatment of their cancer. Moreover, I will have demonstrated my progress towards
advancing NCI-supported clinical trial activities that will help our patients live longer, healthier lives.

Public health relevance
PROJECT NARRATIVE Radiotherapy is routinely employed in the treatment of cancer and can cause a myriad of toxicities that may significantly affect quality of life during and after treatment. Through rigorous clinical research, I aim to optimize the therapeutic index of cancer treatment by maximizing the effectiveness of treatment, minimizing the toxic effects of radiotherapy, understanding treatment toxicity and its effect on short- and long-term quality of life, and developing cancer control and symptom-directed risk mitigation strategies. The proposed research and career development activities outlined in this application will propel me on the path of becoming an independent clinical investigator and ensure that I am successful in advancing cancer clinical research at my institution and within multiple NCI-supported research groups.